Perforin 2 controls unconventional cytokine release from mucosal APC

Perforin 2 controls unconventional cytokine release from mucosal APC
Project Summary
How professional antigen presenting cell (APC) populations focally deliver cytokines to T cells for shaping the
pro-inflammatory vs. anti-inflammatory status of mucosal tissue remains incompletely understood. In particular,
cytokines that lack N-terminal peptide sequence such as the IL-1 family cytokine IL-33 can't access conventional
protein secretion pathways, which has led to the prevailing view that cell death is responsible for IL-33 release.
This project is built upon an exciting set of preliminary data demonstrating that mucosal conventional dendritic
cell (cDC) subsets, in both humans and mice, express the transmembrane pore-forming protein Perforin-2, which
at least in mice, facilitates IL-33 secretion. While in human cDC, we find Perforin-2 expression primarily in an
interferon regulatory factor 4 (IRF4) subset indicating the cDC2 lineage, in mouse cDC, we find Perforin-2 in the
CD103+ cDC1 subset known to express the transcription factors Irf8 and Batf3. Irrespective of this lineage
distinction, both human and mouse CD11c+ cells in the respiratory mucosa contain cytoplasmic IL-33 protein.
Our data demonstrate that inhibition of Perforin-2 activity prevents IL-33 release from cDC and inhibits the
proliferative expansion of a poorly understood ST2+GATA3+Foxp3+Treg subset. Given that Perforin-2 has been
shown to also regulate Type 1 IFN signaling through controlling IFNAR responsiveness, we propose an important
regulatory mechanism exists in humans and mice that is dependent upon mucosal APC that express Perforin-2.
This project tests the central hypothesis that APC require Perforin-2 as an inducible plasma membrane
conduit for unconventional cytokine delivery at the mucosal interface. Three specific aims (SA) will be
investigated. SA1 will determine whether Perforin-2+ APC predict Treg subset abundance in sinonasal mucosa
and define the transcriptional landscape of Perforin-2+ APC. SA2 will define the Perforin-2 domains required for
IL-33 release, the diversity of Perforin-2-dependent secreted molecules, and the requisite intracellular trafficking
machinery responsible for Perforin-2 plasma membrane localization during APC-T cell interactions. SA3 will
directly test whether cDC1 and/or cDC2 subsets preferentially use Perforin-2 for driving pathogen-specific T cell
responses in mouse models of respiratory virus or helminth infection. Taken together, this MIST project stands
to uncover a new paradigm for understanding how cDC instruct immunity within the respiratory mucosa.

Public health relevance
Public Health Relevance Statement Dendritic cells (DC) are professional antigen presenting cells that serve critical roles in both innate and adaptive immune responses. This project investigates how DC focally deliver cytokines like interleukin 33 to T cells for shaping the inflammatory vs. anti-inflammatory responses generated within the respiratory mucosa through mechanisms dependent upon the enigmatic pore-forming protein Perforin-2.